Administrative Core

Administrative Core Abstract
The Administrative Core of the Southern and Central Africa International Centers of Excellence
for Malaria Research (ICEMR) will build on the experience and successes of the prior ICEMR
programs. Over the past 13 years the Administrative Core of the Southern Africa ICEMR
established strong personal, management, and financial relationships with our partner
institutions in Zambia - Macha Research Trust and the Tropical Diseases Research Centre.
These relationships took years to develop and mature and will form the foundation for the
Administrative Core of the Southern and Central Africa ICEMR.
The Administrative Core will provide the leadership, guidance, administrative support, financial
management and oversight to ensure the efficient resource management and success of the
Southern and Central Africa ICEMR. This will be achieved in part by hosting weekly project
meetings with all partners, coordinating meetings of the Scientific Advisory Group, participating
in annual ICEMR meetings, and preparing reports. The Administrative Core’s mid- and short-
term goals are to ensure that resources are managed efficiently and the planned research
activities are coordinated, tracked, reported, and completed within the proposed timelines. The
long-term goals of the Administrative Core are to ensure that the Southern and Central Africa
ICEMR makes substantial contributions to regional malaria control and elimination through
research and capacity building and the scope of work described for the two Research Areas and
the Data Management and Analytics and Computational Modeling Cores.